Developing engineered inhibitors of tRNA modifying enzymes

Project Summary/Abstract
Liver cancer is a growing public health concern, with new cases expected to rise by over 55% by 2040. Liver
cancer was the third most common cause of cancer fatalities in 2020. Hepatocellular carcinoma (HCC)
accounts for over 90% of all liver cancer cases. Current frontline therapies for HCC are inadequate: the 5-year
survival rate for patients is below 15%, making it the second most lethal form of cancer. The goal of this Small
Business Transition Grant proposal is to substantially speed pre-clinical development of a promising new
approach to treat HCC and support the entrepreneurial training of an early career scientist as he assumes a
leadership role in a burgeoning small business. Our research has discovered a new and targetable
vulnerability of HCC cells. HCC cells are dependent on the high expression of multiple tRNA-modifying
enzymes to support their proliferation and metastasis. We have developed a novel therapeutic approach to
irreversibly inhibit these enzymes to slow cancer growth and halt disease progression. Using engineered
tRNAs containing 5-fluoro-uracil (5-FU), an FDA-approved chemotherapeutic agent, we can target multiple
tRNA modifying enzymes using the same molecule. This multi-target activity dramatically increases therapeutic
efficacy. Our preliminary data indicates that CLB-001 has an IC50 that is over 7,000 times lower than that of
free 5-FU alone in HCC cells. Our lead candidate engineered tRNA containing 5-FU, CLB-001, exhibits a
nanomolar IC50 in HCC cells and outperforms the standard of care (sorafenib) in vivo. Notably, CLB-001 has a
wide therapeutic index in vitro and exhibits no signs of toxicity in vivo at effective dose levels. To advance the
pre-clinical development of our therapeutic tRNAs, we will: (1) Develop additional in vitro-optimized therapeutic
tRNAs for HCC treatment, (2) validate the efficacy of these tRNAs in patient-derived tumoroid models of HCC,
(3) perform preliminary dose-escalation toxicology studies in mice, (4) demonstrate in vivo efficacy in
orthotopically-implanted patient-derived xenograft and syngeneic models of HCC, and (5) obtain pre-clinical
pharmacokinetic and toxicology data in rats on the pathway to an IND submission. The development of a
therapeutic tRNA as a potent HCC therapy has the potential to improve the clinical outcomes for millions of
HCC patients worldwide.

Public health relevance
Project Narrative Over 1 million people will be diagnosed with Hepatocellular Carcinoma (HCC) annually by 2025. HCC patients face a limited suite of treatment options, and have a 5-year survival rate below 15%. The goal of this Small Business Transition Grant proposal is to substantially speed pre-clinical development of a promising new approach to treat HCC. Additionally, we propose a multifaceted mentoring program tailored to support an early career scientist as he assumes a leadership role in a promising small business that is commercializing these novel HCC therapeutics.